1/2 Women's Aneurysm Research: Repair Immediately Or Routine Surveillance: WARRIORS trial

Project Summary
Abdominal Aortic Aneurysm (AAA) repair is typically recommended when the aneurysm diameter reaches 5.5
cm, based on studies that primarily included men. Women, however, face a fourfold higher risk of AAA rupture
at smaller diameters and nearly double the mortality following surgery. This discrepancy raises critical
questions about whether women should undergo elective AAA repair at smaller diameters than men to improve
survival and quality of life.
The WARRIORS trial (Women’s Aneurysm Research: Repair Immediately Or Routine Surveillance) is an
international, randomized controlled trial designed to address this issue by comparing early elective
endovascular aortic repair (EVAR) with routine surveillance in women aged 50+ with small (4.0-5.4 cm)
asymptomatic AAAs suitable for EVAR. The trial will enroll 1,112 women globally, including 350 in the United
States, with 1:1 randomization stratified by age, country, and aneurysm size.
The primary outcome is AAA-related mortality and rupture over five years, while secondary outcomes include
quality-adjusted life years (QALYs), operative mortality, loss of EVAR eligibility, and cost-effectiveness. The
trial’s innovative design incorporates registry-supported data collection, novel electronic health record
screening for patient identification, and extensive patient and community engagement to ensure broad
representation and minimal loss to follow-up.
The trial meets criteria for NHLBI’s strategic goals and objectives i.e. Objective 3: Investigate factors that
account for differences in health among populations. By determining whether women should have different
criteria for AAA repair, the WARRIORS trial aims to establish sex-specific clinical guidelines, ultimately
advancing health equity and improving outcomes for women with AAAs.

Public health relevance
Project Narrative This project addresses the critical gap in knowledge regarding the appropriate diameter threshold for elective AAA repair in women, who are at a higher risk of rupture and post-surgical mortality compared to men. By conducting the WARRIORS trial, an international randomized controlled study, we aim to determine if early elective EVAR improves survival and quality of life for women with small AAAs. The findings will inform sex- specific clinical guidelines, advancing health equity and optimizing care for women with this life-threatening condition.